Long-term neurocognitive outcomes of HIV-exposed uninfected children

ABSTRACT
Climate change disproportionately affects vulnerable populations, including those of lower socioeconomic status,
people living with HIV, and young children living in low-resource settings. Malawi has seen a massive increase
in extreme weather events related to climate change in recent years, culminating in Cyclone Freddy, believed to
be the longest-lasting and highest force cyclone ever recorded, which hit Malawi on March 11th. Independent of
direct morbidity or mortality due to drowning or blunt injury, Cyclone Freddy may have severely impacted the
health of Malawian children through exposure to a broad range of infectious diseases, and increased
experiences of psychosocial adversities resulting in prolonged periods of toxic stress. We are currently following
a cohort of mothers (recruited in the third trimester of pregnancy) and infants being followed up to five years of
age in three categories: (1) children HIV exposed and uninfected (CHEU) born to women diagnosed with HIV at
the first antenatal visit, thus exposed to uncontrolled viremia for at least half of gestation; (2) CHEU born to
women initiated on ART prior to conception with undetectable viral loads; and (3) infants born to HIV uninfected
mothers. Our goal is to conduct rigorously validated longitudinal assessments of neurocognitive development
and biological and psychosocial factors which may play a role in child development. We are leading one of the
first studies of CHEU in resource-limited settings to simultaneously address the impact of biological and
psychosocial factors on neurocognitive development. In this supplement, we are planning to incorporate climate
change information into our assessment of the impact of maternal HIV infection and the post-natal environment
on long-term health and neurocognitive outcomes in children. Our evaluation will include assessing the impact
of Cyclone Freddy and other extreme weather events on neurocognitive development in HIV-exposed infants by
evaluating the impact of these factors on the family’s quality of life as reported by the mother and exposure to
vector-borne infections. We will test the following hypotheses: 1a: Cyclone Freddie will lead to increased rates
of maternal depression, increased severity of exposure to childhood adversity, and decreased quality of housing.
The impact will be greatest among mothers living with HIV. 1b: the neurocognitive development of infants in
households that report significant impacts of the cyclone is likely to be delayed compared to households which
do not report major impacts. 2a: Extreme weather events will lead to an increase in arboviral exposure, this effect
will be greatest among households with lower SES, CHEU, and mothers living with HIV. 2b: Exposure to
arboviruses will be associated with poorer neurocognitive scores at five years of age, particularly among CHEU.
This research will measure the impact of these climate-related factors on the health and well-being of HIV-
exposed compared to HIV-unexposed children. We hypothesize that climate change will have a disproportionate
impact on children born to mothers with HIV-infection and therefore will require additional interventions to
develop climate resiliency in childhood.